Cultural adaptation of a mobile caregiver intervention for Hispanic dementia caregivers

Project Summary
Hispanics are the fastest growing minority population in the U.S., they are 1.5 times more likely to
develop Alzheimer’s disease and related dementias (ADRD), and Hispanic ADRD informal caregivers
experience more burden the White non-Hispanics. There is an identified need to adapt interventions and
make them culturally relevant to meet the needs of Hispanic ADRD informal caregivers. My past research has
focused on examining cultural factors as they related to ADRD cognition and symptomatology. In the
proposed K23 application, I aim to fill an existing gap in my training by applying the knowledge I’ve gained in
regard to cultural factors among Hispanic ADRD populations and gain experience and training in clinical trial
research and methodology. I plan to pursue a career as an independently funded investigator in the field of
culturally tailored interventions for ADRD Hispanic caregivers and patients. The proposed study will use a
mixed method approach to conduct the necessary stage 0 and 1A activities of the NIH Stage model to assess
needs of Hispanic ADRD informal caregivers and develop modifications to Brain CareNotes, a secure mobile
telehealth application for informal caregivers to manage behavioral and psychological symptoms of dementia
(BPSD) with the aid of a remote care coach. Preliminary data on a general sample have shown that BCN
reduced caregiver burden (Neuropsychiatric Inventory [NPI]-Caregiver Distress) and BPSD at 3 and 6
months. Culturally tailoring this intervention requires more than just Spanish translation, but integration of
cultural factors which effect psychological and neurological functioning in both caregivers and ADRD patients.
Guided by an equity focused framework, PROGRESS Plus, I propose to culturally tailor BCN for Hispanic
ADRD caregivers. This will be accomplished by first conducting a needs assessment among Hispanic ADRD
informal caregivers (aim 1) in relation to managing BPSD and how equity factors play a role. I will then use
participatory co-design methods to adapt and modify Brain CareNotes (aim 2). Once the cultural adaptations
are complete, I will conduct a pilot study to ensure a future R01 proposed RCT will be powered to detect
reduction in Hispanic caregiver burden and BPSD among ADRD patients (NPI scores).

Public health relevance
Project Narrative The proposed K23 study will significantly contribute to public health by assessing the needs of a minoritized population, Hispanic informal caregivers of patients with ADRD, and culturally tailoring an existing caregiver mobile intervention with the long term goal of providing a scalable and effective intervention for this population.